Targeting CISD1-mediated ferropoptosis in head and neck cancer

PROJECT SUMMARY
Late-stage, HPV-negative (HPV-) head and neck squamous cell carcinoma (HNSCC) (or HNC-) is the most lethal
HNSCC subtype. HNC- occurs at the highest incidence in the Appalachian region, where a large segment of this
population is rural, economically disadvantaged and medically underserved. The Appalachian population has
the highest tobacco use in the nation, a behavior directly linked to disparities in HNC- incidence and mortality.
As such, there is a pressing need to identify novel therapeutic targets for efficacious treatment of HPV- cancers
in Appalachia and beyond. Increased iron-regulation contributes to rending cancer cells resilient to conventional
chemotherapeutic treatment. CISD1 (MitoNEET) is a redox-active iron-sulfur [2Fe-2S] containing protein that
functions in the outer mitochondrial membrane to regulate cellular bioenergetics and support Fe-S cluster repair
during cellular stress encountered in chemotherapy. Ferroptosis is a specialized form of programmed cell death
that results from iron dysregulation. Informatic studies indicate that CISD1 overexpression is a novel ferroptosis-
related prognostic marker across multiple cancer types, where its overexpression in HNC- and other cancers is
associated with poor overall and progression-free survival. Our pilot data shows that CISD1 is overproduced in
several Appalachian HNC- cell lines and PDX tumors. Loss of CISD1 function by pharmacologic inhibition or
knockout reduces cell proliferation in several cancer types through mitochondrial-based bioenergetic
mechanisms. Since Fe-S cluster biosynthesis is upregulated in cancer compared to non-cancerous cells, CISD1
inhibitory ligands represent a novel class of chemotherapeutics with the potential to avoid overt toxicity in normal
cells. However, the optimal delivery mechanism of selective ligands targeting CISD1 to test efficacy in HNC- is
not known. Our central hypothesis is that CISD1 inhibition serves as novel chemotherapeutic approach in the
treatment of HNC- to cause mitochondrial dysfunction and ferroptosis-mediated reduction of cell proliferation and
survival. Aim 1 will determine the role of CISD1 on ferroptosis in the HNC- through gain and loss of function
assays. Aim 2 will develop a novel lipid nanoparticle formulation to deliver the first in class CISD1 inhibitor NL-
1 in combination with CISD1-targeting siRNA and the approved HNSCC-targeted therapeutic cetuximab (Erbitux)
to patient-derived xenografts of HNC- in mice for enhanced anti-cancer activity. Results from this proposal will
provide a foundation for future studies that will mechanistically address a novel tumor-supporting mechanism
identified from this work as a driver of HNC- disease aggressiveness. This work will be the first to demonstrate
CISD1 as a potential a new target for further therapeutic development in order to improve treatment of this highly
refractory disease in the Appalachian and other populations with disparate HNC- incidence and mortality.

Public health relevance
PROJECT NARRATIVE This study will provide new information on how the deadliest form of head and neck cancer utilizes iron biochemistry to drive worse clinical outcomes. The proposal will evaluate the role of ferroptosis, which has not been previously well studied in oral cancers. Novel drug delivery technology will be designed and utilized to selectively deliver ligands and inhibitory RNA to a ferroptosis target in head and neck cancer cells and tumors, with the goal of reducing toxicity to normal tissues and improving overall quality of life in high risk patients.